CNS Effects of Alcohol: Cellular Neurobiology

Abstract Overall
The Scripps Research Institute-Alcohol Research Center (TSRI-ARC) will focus on the cellular and molecular
mechanisms that modulate top-down medial prefrontal control of the central amygdala and underlie stress-
induced vulnerability to relapse and excessive drinking during protracted abstinence. Our approach consists of
coordinated interdisciplinary molecular, neuroproteomic, cellular, neurocircuitry, connectomic,
neuropharmacological, and behavioral methods. Specific hypotheses are: (1) Protracted abstinence involves
increased vulnerability to stress-induced relapse via changes in modulatory control circuitry from the infralimbic
cortex to the central nucleus of the amygdala. (2) Modulatory control changes are a function of altered
glutamatergic and γ-aminobutyric acid synaptic transmission, due to actions of stress-related molecules
(including hypocretin, corticotropin-releasing factor, dynorphin, and nociceptin) and astrocytic dysfunction. (3)
These neurocircuitry changes are associated with altered connectivity and decreased modularity of brain
networks, leading to increased vulnerability to stress-induced relapse. (4) Novel translationally relevant ligands
of neurobiological targets identified by TSRI-ARC will attenuate the reinstatement of stress-induced alcohol
seeking, excessive drinking, and stress-related behaviors in animal models. Our Center-wide aims will be met
by 5 Research Components (Functional Connectomics, Neuropharmacology, Molecular, Neurophysiology, and
Neurocircuitry), and 4 Cores (Administrative, Dissemination, Animal Models, and Neuroproteomics). The
Administrative Core is organized to optimize Center-wide functioning, utilization of Core resources, and research
collaborations in the Center-at-Large. TSRI-ARC is structured to promote Diversity, Equity, and Inclusion (DEI),
training and career development at all levels of the Center. TSRI-ARC rapidly disseminates its discoveries to
scientific, healthcare and lay stakeholders, and engages young people from health disparity backgrounds for
internships in TSRI-ARC laboratories to learn about alcohol and careers in alcohol research. Center-wide
Specific Aims are: (1) To characterize the cellular and molecular mechanisms that modulate top-down medial
prefrontal control of the central amygdala and underlie stress-induced vulnerability to relapse and excessive
drinking during protracted abstinence. (2) To understand how reversal of the cellular and molecular stress
mechanisms that impair modulatory control systems can prevent stress-induced relapse and excessive drinking
during protracted abstinence. (3) To evaluate the efficacy of neuropharmacological targets identified by TSRI-
ARC for reversing dysregulated connectivity within and between brain stress systems and modulatory control
circuits in protracted abstinence. The ultimate goal of TSRI-ARC is to positively influence public health by
generating data relevant to the identification of neurobiological mechanisms mediating alcohol use disorder
(AUD), and guide the translation of our basic research findings toward clinical applications to help in prevention,
diagnosis, and treatment of individuals with AUD.

Public health relevance
Narrative It is well established that most individuals with alcohol use disorder (AUD) can briefly quit drinking, but a significant challenge is to not relapse to excessive drinking following a period of abstinence. The TSRI-ARC renewal addresses key gaps in our understanding of AUD, in that it focuses on the less well-understood persisting heightened neurobiological stress responses and impaired cortical control that may drive drinking relapse. The overall goal of TSRI-ARC is to identify fundamental neurobiological mechanisms mediating AUD, and guide the translation of our basic research findings toward helping individuals recover from AUD.